Capturing body segment changes during pregnancy to develop an accurate biomechanical model.

Project Summary
Kinetic assessment (i.e. the forces and torques acting about a joint) of an individual
performing a task requires the unique physical attributes of that individual as input parameters.
These attributes are called body segment parameters (BSP) and include mass, center of mass
location and moment of inertia. Individuals in the workforce who become pregnant often chose
to continue to work for a multitude of reasons. Unfortunately, there are no known ergonomic
standards and protocols for this unique population that are based on kinetic assessments, as
there are for the general population. Furthermore, there are no known longitudinal
anthropometric measures of the changes in the trunk and other body regions during pregnancy,
other than that related to whole-body measures, such as body mass index (BMI) and body fat-
related measures. The goal of this proposal is capture accurate longitudinal BSP estimates and
anthropometric measures along the stages of pregnancy, from which models specific to this
unique population can be developed.
Specific aims:
1) An accurate set of BSP estimates is needed to better understand the physical nature
of how the different segments within an individual change during pregnancy.
2) Establish a geometric and two regression-based models (of different complexities
and associated accuracy) that are specific to the pregnant population and to the stage
of pregnancy. These models will be readily available to the public and can be
implemented into biomechanical motion analysis software for all to use.
3) Changes in anthropometric measures of a pregnant body (e.g. trunk dimensions) are
necessary to develop attire and equipment, and protocols relative to the stage of
pregnancy.
It is hypothesized that these aims will open an avenue along which empirical-based
biomechanical assessments of pregnant individuals performing different tasks will begin to
catch up to that of the general population. The long-term plan is to further develop the models,
specific to different pregnant morphologies. More importantly, the true nature of how pregnant
individuals perform various daily living and work-related tasks can be properly examined and
will ultimately lead to standards, protocols, equipment design and the like that are based on
sound empirical data.

Public health relevance
Project Narrative This project will accurately determine the longitudinal changes in physical characteristics through the different stages of pregnancy. With this knowledge, we can begin to biomechanically analyze how pregnant individuals perform different occupational tasks as they learn to adapt to their rapidly changing bodies. In turn, we can develop occupational standards and protocols unique to the pregnant population that are based on sound empirical research.